IVD-CANCER PREVENTION FOR HISPANIC WOMEN

Following on a Phase I study, the objective of this Phase II application is to develop and evaluate an innovative Level III Interactive Videodisc for Cancer Prevention (IVD-CP) for Hispanic women. The primary focus of the materials will be on breast and cervical cancer prevention. specific aims include: (1) Development of a full interactive videodisc for the intended audiences of Hispanic women and their health care providers; (2) Conduct of formative and outcome evaluation activities, with particular emphasis on acceptability to potential public and professional users; and (3) Identification of appropriate distribution modalities. Unique elements of this application include the particular focus on Hispanic women, with an emphasis among those who have low levels of income, literacy, and acculturation.